Administrative Core

CORE A: PROJECT SUMMARY/ABSTRACT
To maximize the cohesiveness and impacts of the Georgia Center for Diabetes Translation Research
(GCDTR), Core A (the Administrative Core) provides the leadership, infrastructure, oversight, administrative
support, and promotion and dissemination functions. GCDTR has retained and expanded a diverse team of
leaders (including specific senior leadership for equity) to serve on the Executive Council and involved them in
developing the center’s vision, mission, conceptual framework, and administrative processes over the past 4
years (GY 1-4). The GCDTR Director and Executive Council have raised considerable personal and matched
financial support for the GCDTR which will be used to nearly quadruple annual Pilot and Feasibility (P&F) grant
awards. Core A has an illustrious group of Internal and External Advisory Committee members to continue to
provide advice and direction on center management, strategy, growth, and impact regionally and nationally. In
this renewal, we have formed an Junior Faculty Advisory Committee to gather actionable feedback from a key
GCDTR user group, establish processes for peer mentoring to support them, and link and sponsor aspiring
diabetes translation investigators to opportunities and networks. Core A has developed transparent
administrative policies and processes, including regular evaluation, reporting, and revision of annual strategic
goals, ensuring that oversight and strategic growth of the Center are parallel and complementary goals.
Administrative processes are not intended to be onerous, but rather, to stimulate efficiency and cohesiveness
across the center, and to intentionally promote the overarching vision of equity. Specific Core A activities will
include: annual strategic planning; administration of funds to Cores and Programs (funds derived from the
grant, matched funds sponsored by partner institutions, and funds derived from service pay-back
mechanisms); serving as the forum for regular Executive Council progress updates and strategy discussion;
monitoring equity metrics for GCDTR membership, Enrichment, and Pilot and Feasibility (P&F) activities;
internal and external annual progress reviews and reporting (for the Internal and External Advisory Committees
and the NIH); promoting recruitment, enrichment, retention, and collaboration across campuses (working
closely with key institutional partners, University Department Chairs and Deans, through the P&F and
Enrichment Programs, and through the dedicated Junior Faculty Advisory Committee, with a Representative
role on GCDTR’s Executive Council); and supporting the Regional Core in relationship management and
dissemination of scientific data to GCDTR Faculty, regional affiliate institutions and members, and the broader
community. Through its mix of experienced processes and personnel, the Administrative Core is poised to
further increase GCDTR’s visibility, reputation, growth, and impacts on diabetes translation research and
diabetes outcomes in the Southeast.